EFFECTS OF MATERNAL PHENYLKETONURIA ON PREGNANCY OUTCOME

This study is designed to provide information on the question of whether fetal damage occurs at any level of maternal hyperphenylalaninemia or only when the mother has classic PKU (phenylketonuria).